Identification of Genetic and Molecular Pathways in Congenital Rare Disorders Affecting the Brain and Muscle

ABSTRACT
Congenital muscular dystrophies (CMDs) are a group of heterogeneous pediatric disorders leading to motor
and developmental delay, and childhood mortality. CMDs have variable presentation often affecting multiple
organs, such as the eyes and brain. While this clinical heterogeneity initially hindered genetic analyses, the ad-
vent of next-generation sequencing and whole exome studies greatly increased gene identification reaching up
to 30 genes, with eight genes identified in 2012-2013, three of which by the PI. Each new gene has provided a
different piece of a complex puzzle, not only providing a genetic diagnosis for the affected individuals, but also
informing us on how the mutated genes converge onto shared molecular pathways such as protein glycosyla-
tion. Yet, our group and others have found that mutations in each gene are only present in a small portion of
cases, and 30-40% of cases remain unexplained. In parallel, the large number of known genes has hindered
therapy development as it remains unclear how cases with different genotypes and phenotypes can be grouped
for treatment.
The PI has focused the past decade on studying the genetics of CMD and developing zebrafish models to define
how disease-causing mutations affect muscle and brain development. Through these studies, we have devel-
oped our central hypotheses that most CMD genes regulate interactions with the extracellular matrix (ECM)
through glycosylation, and that unexplained cases will either carry mutations in novel genes involved in cell-
ECM interaction or noncoding variants in already known CMD genes. The proposed studies will test these
hypotheses through two independent and complementary Specific Aims. Specific Aim 1 will leverage the multi-
ple zebrafish models we have developed for known CMD genes to test whether increasing glycosylation will
restore cell-ECM interactions in the muscle and brain in different genetic models of CMD. We will 1) define
which biochemical deficits are shared by different genetic mutations in muscle cells and neurons, and 2) test
whether changes in glycosylation can be beneficial in different forms of CMD. This workflow can then be ex-
panded to future therapeutic interventions and novel disease genes can be rapidly taken from gene identifica-
tion to therapy evaluation. Specific Aim 2 will close the gap in gene discovery in CMDs by testing the hypothe-
sis that undiagnosed CMD cases are caused by a combination of rare mutations in novel genes and non-
coding mutations in intronic/regulatory regions of known CMD genes. We have developed a next generation
sequencing and bioinformatic pipeline that will integrate data from exome, genome, and transcriptome to iden-
tify coding, splicing, and regulatory variants to fully unravel the genetics of CMD.
These studies will directly impact the CMD fields by both discovering how different disease genes contribute to
pathogenesis and by developing novel genetic tests for the global patient population.

Public health relevance
PROJECT NARRATIVE Congenital muscular dystrophies (CMDs) are a group of severe pediatric disorders leading to early mortality or profound motor and cognitive disability. These disorders can be caused by many different genes with variable severity and half of the cases still do not have a known genetic cause. The goal of our research is to identify all genes involved in CMDs to understand how they work in concert to disrup development of the muscle and brain and develop novel therapies.